ASCVD risk assessment in T2DM facilitated by novel computational immunology programs

Project Summary
Type 2 diabetes mellitus (T2DM) is a primary cause of the marked increase of ASCVD, accounting for over 30%
of symptomatic cases. Accordingly, the ASCVD risk in T2DM patients is 2-4 fold more than in the non-T2DM
population. The concomitant increase of T2DM and ASCVD in the US prompted the urgency for accurate ASCVD
prediction followed by an effective mitigation strategy. However, recent clinical trials and extensive cohort studies
revealed underachievement by controlling conventional lipid/hypertension/glycemic factors, warranting new
directions additional to the existing mitigation paradigm. Furthermore, multiple studies comparing existing
ASCVD risk prediction models, including those derived from general or T2DM populations, achieved only
marginal or underperformance in multiple independent cohorts, endorsing the significance of this significant
unmet biomedical challenge. Our proposed study aims to fill this critical scientific and clinical gap in increased
atherosclerosis cardiovascular disease risk (ASCVD) in T2DM. Supported by our recent discoveries and
development of multiple immune cell annotation tools, we propose to test the overarching hypothesis that the
foaming process in circulating monocytes can be directly altered by T2DM towards pathogenic foaming, thus
directly contributing to the elevated risk of ASCVD. Application of our newly developed cell function annotation
tools uncovered distinct macrophage-derived foam cell development programs, followed by ASCVD causal gene
signature identification and proof-of-concept ASCVD predictive modeling by incorporating a selected gene list
using the original machine learning program. Our new work further revealed that super-networks governed by
three upstream regulators are uniquely altered by T2DM and associated with future ASCVD incidence. Hence,
in two aims: (AIM 1) we will determine the impact of suppressed super-networks governed by identified master
regulators (SNW1, NCOR2, CITED2) on pathogenic foaming program using established foam cell development
system with quantitative methods and single cell transcriptomics; (AIM 2) will assess the efficacy of T2DM-
ASCVD signatures on predictive modeling using existing and innovative feature selection and feature extraction
tools. Completing this project will provide crucial information to significantly advance our understanding of
ASCVD risk in the T2DM population. Our innovative computational programs, derived from novel and in-depth
mechanistic investigation, will offer translatable ASCVD prediction tools and molecular targets for drug
development to achieve personalized intervention for T2DM patients to mitigate ASCVD risks.

Public health relevance
Narrative Albeit intensive mitigation strategies are applied to manage known clinical risk factors, atherosclerotic cardiovascular disease (ASCVD) risks remain high in the type 2 diabetic (T2DM) population. Results using our novel computational programs suggested a T2DM-ASCVD unique super-network could directly contribute to ASCVD mechanistically and predictively. This project will functionally test the impact of these regulators and assess their contribution to improving T2DM-ASCVD predictive modeling.